Nursing Research Conference: Launching New Knowledge; 10 Years and Counting

DESCRIPTION (provided by applicant): Nursing Research Conference: Launching New Knowledge, 10 Years and Counting Abstract Clinically applicable research findings may not be translated into useful practice changes for 10 to 25 years. The purpose of this conference grant proposal is to obtain support for the 10th Annual Cleveland Clinic Nursing Research Conference to facilitate the generation, dissemination, and translation of clinical research knowledge into actionable nursing interventions that improve the health and well-being of patients. Grant funding is being sought to expand the influence of this conference, which has grown each year for the past decade. Many nurses at the Cleveland Clinic are actively involved in the generation and translation of knowledge that impacts nursing practice. Although the ultimate goal of dissemination is to publish research findings, there is a need to provide a forum for clinical nurses to share their research findings with other clinical nurses, and to develop the skills needed to improve the quality of their research. Moreover, this forum decreases the length of time it takes for research knowledge to generate actionable changes in practice that improve patient care. The conference provides an avenue for dissemination of clinical nursing research findings and opportunities for clinical nurses to actively interact and network with experienced nurse researchers. Unlike other nursing research conferences, this conference is specifically planned to meet the unique needs of the clinical nurse who is in a unique position to identify the problems in need of a solution.

Public health relevance
PUBLIC HEALTH RELEVANCE: Nursing Research Conference: Launching New Knowledge, 10 Years and Counting Project Narrative The first step to implementing important new healthcare discoveries is often the presentation of clinical research findings at a professional conference for consideration by colleagues and healthcare stakeholders. Bedside nurses who are involved in research are in a position where they are poised to identify the problems and lead the investigations which turn into evidence-based care for all patients. However, bedside nurses often lack the time and financial support needed to attend costly conferences where their findings can be presented to the scientific community. The Office of Research and Innovation at the Nursing Institute of the Cleveland Clinic has been sponsoring a unique, affordable nursing research conference for the past decade in order to provide a forum to promote nursing research work and provide education and encouragement for the novice nurse researcher. In order to continue the mission of pushing forward nursing research to evidence-based practice well beyond the local and regional level, the conference must expand and draw national and global experts in nursing research, policy, and practice. The plans for the10th Annual Cleveland Clinic Nursing Research Conference are to increase the conference from one to two days and include nationally recognized nurse researchers as keynote speakers. However, with institutional cost-cutting measures in effect, financial support is needed to promote this invaluable forum and continue to disseminate nursing research and education that can rapidly contribute to better healthcare for all Americans.